Systematic identification of interactions between Lyme Borrelia and Ixodes scapularis

PROJECT SUMMARY
This proposal aims to investigate the interactions between Lyme disease bacteria, Borrelia burgdorferi, and
extracellular, secreted and transmembrane proteins (exoproteins) of its common North American tick vector,
Ixodes scapularis. This is an extension of our previous work leveraging a yeast display library comprising over
3,000 human exoproteins to systematically profile human-Borrelia interactions (Cell 2024 Bibliography reference
1) 1. These human studies identified numerous interactions important for Borrelia infection, such as PGLYRP1
with Lyme Borrelia 3 and CD55 4 with relapsing fever Borrelia. Now, we have developed a similar library termed
IscREAM (I. scapularis Rapid Extracellular Antigen Monitoring), of over 3,000 carefully curated exoproteins of I.
scapularis. We propose to screen this library with diverse strains of Lyme Borrelia, and validate top hits by ELISA
and flow cytometry.
Lyme Borrelia interactions with Ixodes exoproteins are critical nodes facilitating pathogen colonization of the
vector, persistence within the tick, and transmission to vertebrate hosts. Better understanding of these
interactions is important for the development of strategies to block transmission or interrupt the disease cycle.
Unfortunately, traditional methods to identify these interactions have been limited in scale. For example, ELISAs
and flow cytometry have been impeded by their experimental throughput, while high throughput methods such
as mRNA capture libraries have been constrained by library quality. IscREAM, on the other hand, mitigates many
of the inherent shortcomings of traditional methodologies through its careful curation and high throughput nature.
IscREAM is comprised of barcoded yeast clones expressing 3,177 individually selected and transformed
exoproteins. This library has been validated with sera of guinea pigs vaccinated against specific I. scapularis
antigens, and we found IscREAM performs with a high degree of sensitivity and specificity. Now, we propose to
mirror our previous human library screens 1,3,4, and probe IscREAM with diverse strains of Lyme Borrelia. To do
so, the IscREAM library will be probed with biotinylated spirochetes, and spirochete-bound yeast clones will be
isolated via magnetic separation with streptavidin coated magnetic beads. Borrelia-binding IscREAM proteins
produced on the surface of the yeast will then be identified by next generation sequencing of protein-specific
genetic barcodes. We will validate top hits by ELISA and flow cytometry.
This effort will yield a database of interactions between Lyme Borrelia and I. scapularis exoproteins. This will
foster further research into potential vaccine targets and prophylactics to impede tick-to-host transmission of
Lyme Borrelia, advancing our ability to combat Lyme disease effectively.

Public health relevance
PROJECT NARRATIVE This proposal seeks to identify interactions between Lyme disease bacteria, Borrelia burgdorferi, and proteins produced by the tick vector, Ixodes scapularis. We have generated a novel yeast display library expressing over 3,000 I. scapularis extracellular, secreted and transmembrane proteins, and we will screen this library with Lyme Borrelia -- building upon our recent successes profiling Borrelia-human interactions. This high-throughput method, and the additional orthogonal validation techniques proposed, will establish a comprehensive database of Lyme Borrelia interactions with these tick proteins, offering insights crucial for preventing tick-to-host transmission of this important pathogen.